Conserved and Unique Features Regulating Meiotic Crossover Formation

PROJECT SUMMARY
All eukaryotes on the planet evolved the ability to form haploid gametes through the specialized cell division
process of meiosis. Central to meiosis is crossover (CO) formation, the exchange of DNA between
homologous chromosomes - a process that both increases diversity and ensures proper segregation of the
homologs. Ironically, COs initiate with the formation of double-strand breaks (DSBs) considered the most
dangerous DNA lesions because mis- or unrepaired breaks can lead to chromosome aberrations including
translocations and inversions, among others. However, if meiotic DSBs are not formed, chromosomes
segregate randomly at meiosis, resulting in aneuploid gametes, and subsequent embryonic lethality or birth
abnormalities upon fertilization. Thus, meiotic break formation must be tightly regulated to ensure that neither
too few nor too many lesions are made. DSBs are catalyzed by the endonuclease SPO11 in collaboration with
accessory factors that regulate number, timing and placement of DSBs. Despite the ubiquity of DSB formation
for meiosis, we know very little about how the different components of the core machinery contribute to these
regulatory functions, in part because germline genes are among the fastest evolving in our genome. This
proposal addresses this critical gap in our understanding by interrogating the interactions between, and
regulation of, the nematode DSB machinery. Our prior studies found that DSB-1 interacts with both SPO-11
and HIM-5 provides a mechanism to bring the break machinery to the chromosome axis where strand
exchange is executed. This grant combines structural modeling, biochemistry, genetics and comparative
evolutionary cell approaches in 3 specific aims. In Aim 1 we propose to perform functional analyses of the
SPO-11 and DSB-1 proteins and the contributions of different domains to the various regulatory aspects of
DSB formation. We will test the hypothesis suggested by our preliminary data that SPO-11 autoregulates its
own activity. We will also create new tools to interrogate SPO-11 binding partners in vivo. Our preliminary
studies have also revealed that the HIM-5 exhibits a tightly regulated nuclear mobilization that is functionally
relevant. We hypothesize that nuclear retention represents a previously unrecognized way to control the proper
timing and repair of DSBs. In Aim 2, we will follow up on these novel observations and address the functional
significance of HIM-5 sub-cellular localization with DSB-1 and its regulation by DSB signaling. In Aim 3, we will
deploy knockdown and gene swaps to interrogate the conservation of the DSB molecular machinery between
C. elegans and C. briggsae, nematodes that have maintained strong synteny and recombination maps despite
100My of independent evolution. We hypothesize that comparisons between the conserved DSBs factors will
shed light both on the core parts of the DSB machinery that maintain tight CO control and on the flexibility of
these factor to adapt to evolutionary forces. Overall, this study will reveal fundamental mechanistic insights into
the regulation and evolution of meiotic DSB formation.

Public health relevance
NARRATIVE During the formation of egg and sperm, DNA breaks are intentionally made to promote genetic exchanges between chromosome inherited from our parents. If not controlled properly, these breaks can lead to mutations that are often incompatible with offspring viability. This research program investigates how the machinery that induces the breaks assembles and is regulated to better understand the causes of human infertility, cancer, and heritable disease.